Fcy Receptor-Mediated Pharmacogenomics of Antibody Therapies in Type 1 Diabetes

PROJECT SUMMARY. Antibody and antibody fusion protein therapies targeting adaptive immune cells have
shown variable inter-subject levels of success at halting autoimmune destruction of the insulin-producing
pancreatic β-cells in individuals recently diagnosed with Type 1 Diabetes (T1D). Responsiveness to many
antibody therapies vary in other autoimmune diseases and cancer according to Fc gamma receptor (FcγR)
variants impacting a patient’s capacity for Fc-mediated mechanisms of action (Fc-MoA) such as antibody
dependent cellular cytotoxicity (ADCC) and antibody dependent cellular phagocytosis (ADCP). Indeed,
pharmacodynamics of low-dose α-thymocyte globulin (LD-ATG) and clinical efficacy of rituximab (α-CD20) have
been demonstrated to be affected by FcγR variants in the context of transplantation or rheumatoid arthritis and
lymphoma, respectively. However, whether responsiveness to these therapies in individuals with T1D are
similarly affected by FcγR-associated variants remains unknown. Therefore, I hypothesize that FcγR-associated
variants may influence efficacy of therapeutic antibodies with FcγR-binding capabilities in recent-onset T1D via
regulation of ADCC and ADCP. Indeed, I have identified a significant association between an FCGR2B
expression QTL (eQTL) and quantitative metabolic response (QR) in the LD-ATG trial (TN19). The objectives of
my proposed studies are to build on this finding by identifying genetic variants in FcγR loci that associate with
therapeutic efficacy in additional completed T1D immunotherapy trials and to evaluate the consequences of
modified FcγR expression and/or function on Fc-MoA. In Aim 1, I will perform quantitative trait locus (QTL)
analysis of FcγR-associated single nucleotide polymorphisms (SNPs) and copy number variants (CNVs) versus
treatment efficacy and target cell depletion in TrialNet (TN) and Immune Tolerance Network (ITN) studies of
native Fc-containing antibody therapeutics in recent-onset T1D. I will analyze associations between genotype
microarray, clinical endpoints, and flow cytometry data from the rituximab (TN05) and alefacept (Inducing
Remission in T1D With Alefacept [T1DAL], ITN) trials. In Aim 2, I will determine impacts of FcγR-associated
variants on cell type-specific FcγR protein expression and regulation of Fc-MoA of therapeutic antibodies for
T1D. Here, I will characterize human whole blood samples by flow cytometry to evaluate associations between
cell type-specific FcγR protein expression and previously defined whole blood eQTLs, with a focus on the LD-
ATG response-associated FCGR2B variant. I will also employ rapid and fluorometric ADCC (RFADCC) assays
to measure LD-ATG- and rituximab-mediated ADCC and ADCP induction by genotype-selected natural killer
(NK) cell and monocyte effectors and T cell or B cell targets, respectively. I expect my findings will support a
precision medicine approach to identify individuals with or at-risk for T1D who are likely to respond positively to
native Fc-containing immunotherapies, as well as to guide dose optimization strategies for non-responders.

Public health relevance
PROJECT NARRATIVE Antibody and antibody fusion protein therapies may halt loss of endogenous insulin production in recently- diagnosed Type 1 Diabetes (T1D) through Fc gamma receptor (FcγR)-associated mechanisms. The goals of this proposal are: 1) to identify genetic variants in FcγR loci that associate with therapeutic efficacy in completed T1D immunotherapy trials and 2) to evaluate the impact of associated loci on FcγR protein expression and function. These studies are expected to aid in generation of a precision medicine strategy to target subjects with or at-risk for T1D who may benefit from immunotherapies with FcγR-associated mechanisms of action.